IMPACTS OF GLIAL LIPID DROPLETS ON OXIDATIVE STRESS AND NEURODEGENERATION IN ALZHEIMER'S DISEASE

Summary – Administrative Supplement
Funded Parent Award (R01 AG073260-02; project ends on 05/31/2026)
The parent R01 is focused on studying the impacts of glial lipid droplets on oxidative stress and
neurodegeneration in Alzheimer's disease (AD). It takes an interdisciplinary approach to further probe
connections between age-related ROS and lipid dysregulation, AD risk factors, Aβ42 accumulation and
Tau in the context of glial lipid droplet formation.
As AD is an age-associated disease, there are likely numerous aging-related features that impact disease
onset and progression, including the dysregulation of lipids and aberrant upregulation of ROS. The parent
grant focuses on how these features impact neuron-glial interactions and AD-associated pathologies,
Aβ42 and Tau, in the nervous system. However, the dysregulation of lipids and ROS is likely to impact
multiple tissues. It is notable that lipid and ROS dysregulation is associated with numerous age-
associated diseases impacting the periphery, including cardiovascular disease, obesity, and intestinal
dysplasia. Fittingly, there is growing interest in understanding the interplay between AD and the periphery
in the context of aging. As such, AD has been connected to disruptions in the gut microbiome, respiratory
system, cardiovascular function, and hormone homeostasis, supporting that peripheral tissues are also
involved in disease. However, a causal relationship between AD progression and peripheral
dysregulation is not well established. Here, we propose to systematically investigate how AD
progression impacts an entire organism at cellular resolution using Drosophila and a cell atlas
approach. Recent advances in single-cell RNA sequencing (scRNA-seq) technologies and the
establishment of the Fly Cell Atlas (FCA) (Fig. 1A) offer an unprecedented opportunity to explore this
potential relationship at the cellular level. The FCA is a single-nucleus transcriptomic dataset in which
over 250 cell types were identified in the whole adult fly. By combining snRNA-seq with lipidomics we
aim to highlight cellular mechanisms within the periphery that are impacted by toxic Aβ42 or Tau during
the aging process. Drosophila is an ideal model system for such investigations as this simple organism,
a rapid lifespan and less redundancies in terms of genes that perform the same or similar functions. This
work targets to characterize how AD progression affects different cell types across the whole organism
and to define interactions with age-associated lipid dysregulation. Based on the criteria for
Administrative Supplements, we believe that our proposal fits very well for the criteria of
availability of a new technology (Li et al., 2022). Further, this supplement is a natural extension of
our funded studies on non-cell autonomous mechanisms and lipid dysregulation that contribute
to AD.
1

Public health relevance
Project Narrative Age-related lipid and ROS dysregulation are involved in AD onset and progression and can also impact disease of periphery tissues. However, a causal relationship between AD progression and peripheral dysregulation is not well established. Here, we propose to systematically investigate how AD progression impacts an entire organism at cellular resolution using Drosophila and a cell atlas approach.